Mechanisms of psychostimulant-sleep interactions

––– PROJECT SUMMARY/ABSTRACT –––––––––––––––––––– R01: Psychostimulant responses and sleep. ––––
Substance use disorder (SUD) and sleep alterations are reciprocally connected in a vicious feed forward cycle.
In one direction, repeated exposure to addictive substances affects sleep timing, duration, and quality. The
effects of drugs on sleep can even last into the abstinence period, during which patients experience irregular
sleep and insomnia, and this persistent sleep disturbance is a strong risk factor for relapse to drug use.
Conversely, sleep disturbances cause stress and mood imbalance and are a risk factor for the development of
SUD. This includes sleep disturbances caused by means other than drugs of abuse, such as shiftwork. Some
neurobiological systems are known to influence sleep as well as motivation and reward. These systems are
often targeted by drugs of abuse, and a substantial body of literature has focused on the disruptive effects of
acute exposure to substance of abuse on sleep. However, mechanistic studies of long-term sleep irregularities
after drug exposure, as well as of how sleep disturbances affect SUD-related behaviors remain scarce. This
application responds to the one-time RFA-DA-25-045 “Mechanistic studies to investigate the interrelationship
between sleep and/or circadian rhythms and substance use disorders”. The goal of this proposal is to identify
genes and molecular mechanisms that affect psychostimulant-induced sleep irregularities as well as sleep
deprivation-caused changes in experience-dependent amphetamine preference (EDAP). We will do so using
the vinegar fly, Drosophila melanogaster, an established genetic model organism with considerable economy
of scale and excellent experimental amenability. Based on preliminary data showing that recovery from acute
amphetamine exposure, which suppresses sleep, leads to sleep rebound, we propose to 1) determine
mechanisms of stimulant-induced sleep changes, including anatomical as well as genetic investigations.
2) We will use within-fly amphetamine exposure to screen Drosophila orthologs of 2 094 human brain-enriched
transcripts for their role in psychostimulant-induced sleep changes. Lastly, we have recently developed a self-
administration assay that monitors EDAP with high temporal resolution, where flies develop preference for
amphetamine within ~12 h, starting from indifference or slight aversion. EDAP depends on Drosophila’s
canonical dopaminergic ‘reward system’. Our preliminary data show that mechanical sleep deprivation
accelerates the development of EDAP and promotes EDAP at lower, normally sub-threshold amphetamine
concentrations, as observed in mammals. We will 3) determine circuit and genetic mechanisms of sleep
deprivation-induced changes in amphetamine preference. Results from these investigations will offer RFA-
relevant “insights into the fundamental processes that link SUDs to disorders of sleep…and vice-versa”.

Public health relevance
–––– PROJECT NARRATIVE –––––––––––––––––––––––––––––––––––––––––––––––––––––––––––––––– Chronic substance use and sleep have a bidirectional interrelationship where continued drug use has long- lasting effects on sleep, and where sleep disturbances pose a risk factor for substance use. The results of the proposed studies will provide valuable mechanistic insight into the genetic and neuronal mechanisms that link psychostimulants with changes in sleep patterns and how latter affect psychostimulant consumption. This work will highlight novel targets for therapeutic intervention with psychostimulant use disorder, which are largely lacking.